Investigation of Cognitive and Affective Deficits Post TBI Using Multimodal Flexible Neural Probes

PROJECT SUMMARY:
Traumatic brain injury (TBI) is a global health crisis, and persistent cognitive-affective symptoms are common
among TBI survivors. Methylphenidate (MPH), a dopamine (DA) transporter (DAT) inhibitor, has demonstrated
improved outcomes with sex differences in the response. Our prior work suggests daily MPH treatment in rats
with experimental TBI helps normalize electrically evoked striatal DA, but the effect on striatal basal DA level
and the postsynaptic striatal medium spiny neurons (MSNs) has not been investigated. The other major striatal
input, glutamatergic cortical neurons, can contribute to TBI-induced excitotoxicity. We hypothesize ongoing
Glu-induced excitotoxicity post-TBI not only reduces tonic [DA] firing but also limits MSN outflow via
MSN damage, consequently leading to DA transmission dysfunction and cognitive-affective deficits that
are rescued by MPH. A detailed investigation of the striatum, including its inputs (DA/Glu) and output (MSN
firing) is critical to understand TBI-induced striatal damage, behavior effects, MPH mechanisms and sex differ-
ences to customize treatment for TBI patients. To enable such investigation, we will develop a multimodal mi-
croelectrode array (MEA) to monitor the rat striatum for 3 wks after TBI and MPH, and correlate MSN neural
activity, basal [DA] and [Glu] to molecular and behavioral assessments.
Current state of art MEAs typically use one modality or assess one analyte, and suffer from chronic recording
or sensing degradations due to biofouling, inflammatory tissue reaction, or sensor/electrode material degrada-
tion. TBI exerts additional mechanical and biochemical challenges to the implanted device, and its effect on
device function is unknown. By pairing novel square wave voltammetry with a poly(3,4-ethylenedioxythio-
phene)/acid functionalized carbon nanotube (PEDOT/CNT) coating, we have achieved basal DA sensing in vivo
for 3 wks. Meanwhile, an innovative nanoparticle technology shows promise in stabilizing Glu oxidase, allowing
for selective functionalization of individual electrode sites for Glu sensing. Additionally, flexible substrates and
antifouling coatings have independently shown benefits in the seamless tissue integration of MEAs. The goal of
this project is to take advantage of these novel technologies to build a flexible MEA that can chronically
interrogate striatal DA & Glu neurotransmission while recording striatal MSN firing, in order to advance
our understanding of biological mechanisms underlying sex-specific cognitive-affective symptoms and treatment
post-TBI. To accomplish this goal, we will 1) develop and optimize a flexible multimodal MEA for in vivo sensing
of basal [DA] and [Glu], and neural recording in naïve rats, 2) investigate TBI effects on device performance, and
3) explore striatal mechanisms of cognitive-affective symptoms after TBI and MPH treatment using recorded
striatal neural activity and basal [DA/Glu] paired with behavioral, molecular, and histological analyses to build a
holistic mechanistic picture of the striatum post TBI and treatment.

Public health relevance
Narrative: Traumatic brain injury (TBI) can cause persistent cognitive-affective symptoms with few effective treatments. We will develop a multifunctional microsensor that can be implanted in the brain regions of interest, to monitor neuron activity and neurotransmitter levels, after TBI, in order to understand the biological origin of the symptoms and identify effective therapy.